Role of E3 Ligase UBR5 in Alternative Splicing during B Cell Development and Activation

ABSTRACT
Proper B cell development is an essential part of innate and adaptive immunity. Coordination of a
number of molecular mechanisms are required to facilitate B cell development, maturation, activation, and
survival of B cells. Recently, the ubiquitin E3 ligase, UBR5 has been found mutated in a significant number of
cases of patients with mantle cell lymphoma, implicating the E3 ligase in B cell development. UBR5 is a key
regulator of DNA damage repair, transcription, translation, and our data suggests mRNA splicing via the
spliceosome. UBR5 is a HECT domain ligase, which contains a cysteine residue that is responsible for
ubiquitin transfer to its substrates. To elucidate the role of UBR5 in B cell maturation and activation we
generated a conditional mutant disrupting the C-terminal HECT domain. Loss of the HECT domain leads to a
block in maturation of B cells in the spleen with a reduction of B1 and marginal B cell subsets, as well as
phenotypic alterations and functional defects of follicular B cells. Proteomic studies reveal up-regulation of
spliceosome proteins in B cells lacking the HECT domain of UBR5, and that UBR5 interacts with splicing
factors. To further understand the functional role of UBR5 in regulating B cells activation and maturation and
the consequences of aberrant spliceosome component expression, we will define the role of UBR5 during
germinal center formation and activation (Aim 1), determine the ubiquitin independent vs. dependent function
in B cells (Aim2), and identify the role of spliceosome and altered transcripts in B cell activation (Aim 3). These
studies will unravel a novel role of UBR5 in B cell maturation by regulating alternative splicing of key transcripts
during B cell development.

Public health relevance
Narrative Molecular mechanisms regulating B cell maturation and activation are essential for function of the immune system. Here we will study the role of ubiquitin E3 ligase, UBR5 and the spliceosome during B cell maturation. Deciphering role of UBR5 in B cell development and provide clues to novel pathways regulating immunity.